Development of a Pediatric Rheumatology Common Data Element set (CDE) for Juvenile Idiopathic Arthritis

PROJECT SUMMARY
This conference and associated consensus process will create a bundle of NIH-endorsable consensus
Common Data Elements (CDE) specifically targeted to advance research efforts according to FAIR principles in
Juvenile Idiopathic Arthritis (JIA), the most prevalent pediatric rheumatic disease (PRD), for which no current
effort to create a CDE exist or is in-process. Creation of consensus-driven CDEs for JIA will facilitate study of
this and other PRDs diseases across research projects in pediatric rheumatic diseases and other autoimmune
diseases, furthering the scope and generalizability of research in rheumatic diseases across the lifetime. The
JIA disease domain appears readily amenable to the processes needed for consensus CDEs to be formally
defined, mapped to existing data elements from major existing efforts, and submitted in a format that will
enable endorsement by the PRD community and NIH. We therefore propose a consensus driven process to
enable a final product of an NIH-endorsable CDE for JIA, with the aims of (1) expert identification and collation
of existing data elements, including from major existing research efforts; (2) a virtual conference for JIA CDE
consensus development, conducted using modified Delphi methodology that has been successfully utilized for
generation of multiple consensus efforts in the past; and (3) creation of NIH-endorsable bundles of consensus-
based CDEs for JIA. As a final product, we will collate and compile responses from the respective consensus
conference meetings into a JIA CDE bundle. This will be prepared in both text-based, human readable format
and machine-interpretable formats (e.g. data dictionaries, code lists), with inclusion of metadata and
conversion to formats suitable for inclusion in the NIH CDE repository.

Public health relevance
PROJECT NARRATIVE This conference and associated consensus process creates a bundle of NIH-endorsable consensus Common Data Elements (CDE) specifically targeted to advance research efforts according to FAIR principles in Juvenile Idiopathic Arthritis (JIA), the most prevalent pediatric rheumatic disease (PRD), for which no current effort to create a comprehensive set of CDEs exists or is in-process. Creation of a set of consensus- driven CDEs for JIA will facilitate clinical trials for JIA, furthering the scope and generalizability of research in rheumatic diseases across the lifetime. Two collaborative conference sessions will be conducted, followed by two to four collaborative work/focus sessions, during which a modified Delphi process will be utilized to arrive at consensus. Following this, the final product of NIH-endorsable CDEs will be completed and submitted, in consultation with NIH program staff.